Diagnosing and predicting risk in children with SARS-CoV-2- related illness

Multisystem Inflammatory Syndrome in Children (MIS-C) caused significant morbidity and mortality in children
during the COVID-19 pandemic, but we know little about the molecular pathogenesis or response to treatments
for children with MIS-C. The goal of this administrative supplement is to harness the strength of
collaboration and expertise from PreVAIL and evaluate the molecular signature of MIS-C pre- and post-
treatment to better understand the response to different treatments. Therefore, this application is
responsive to NOSI NOT-HD-22-003. Children with MIS-C presented with fever and some had rash,
conjunctival injection, erythema of the lips, and even coronary artery dilation, all signs associated with
Kawasaki disease (KD). For this reason, when the first patients presented to intensive care units in Italy,
England and then the East Coast of the United States, physicians reached for many of the therapeutics used to
treat KD. While some patients improved with intravenous immunoglobulin (IVIG) alone, more than 70%
required treatment with steroids, anakinra (IL-1 blockade) and/or infliximab (TNFα blockade). As there was
clinical equipoise as to which of these therapies was best for treating MIS-C, our PreVAIL kIds (Predicting
Viral-Associated Inflammatory Disease Severity in Children with Laboratory Diagnostics and Artificial
Intelligence Initiative) team at UC San Diego designed and launched a two-site randomized, clinical trial
(Multisystem Inflammatory Syndrome Therapies in Children (MISTIC) Comparative Effectiveness Study). The
goal was to determine which combination of therapies (IVIG with steroids, infliximab and/or anakinra) was most
effective in reducing morbidity and mortality in children with MIS-C (NCT04898231). This study enrolled 74
subjects and is now closed for enrollment and under analysis using a novel Bayesian joint stage model applied
to the snSMART design. As part of MISTIC, serum, plasma and whole blood RNA were collected pre-IVIG and
12 hours after IVIG or the first-randomized therapy. In this administrative supplement, we will evaluate the
molecular signature of MIS-C pre- and post-treatment through whole blood (wb) RNAseq, plasma cell
free (cf) RNA, and plasma proteomics to better understand the response to different treatments
administered to children with MIS-C. We propose three specific aims to achieve this goal. Specific Aim 1
will analyze the wbRNA profiles using RNAseq of MIS-C patients before and after IVIG therapy, and after
infliximab, anakinra, and steroid treatment. Specific Aim 2 will analyze the cfRNA tissue of origin profile of
MIS-C patients before and after IVIG therapy, and after infliximab, anakinra and steroid treatment. Specific
Aim 3 will analyze the plasma proteome of MIS-C patients before and after IVIG therapy, and after infliximab,
anakinra and steroid treatment. The synergistic expertise of these two PreVAIL teams in this multi-center
proposal provides a unique opportunity to understand the pathophysiology and response to treatment of MIS-
C, as well as potentially develop biomarkers for this acute, inflammatory condition.

Public health relevance
Project Narrative As the COVID-19 pandemic evolved in early 2020, case reports appeared describing children with unusual febrile illnesses with elevated inflammatory markers and multi-system involvement that is now termed Multisystem Inflammatory Syndrome in Children (MIS-C). Despite MIS-C being the most severe illness in children during the pandemic, little is known about how the body responds to this illness or the response to different treatments. To address an urgent, unmet clinical need, investigative teams will join forces to understand the molecular response to treatments of MIS-C.